Models, mechanisms and treatment of LMX1B-induced glaucoma

High intraocular pressure (IOP) is a major causal risk factor for glaucoma and is the target of all
current glaucoma therapies. Although the importance of the LMX1B genes in human primary
open-angle glaucoma (POAG) has clearly been demonstrated, the mechanisms by which
LMX1B mutations induce IOP elevation and glaucoma are not known. This project investigates
the molecular mechanism by which abnormalities in LMX1B impact IOP and contribute to
glaucoma. It will generate a more sophisticated understanding of a human glaucoma gene,
ultimately guiding new treatments. Additionally, it will provide well characterized LMX1B
glaucoma models to the community. Current IOP-lowering drugs are not effective in many
patients, and reduce IOP by no more than 25-30%. Surgery to provide new aqueous humor
(AQH) outlets often fails due to scar formation. Therefore, new IOP-lowering therapies are a
critical need. New pathways and candidate molecules must be identified to advance
development of more potent and specific anti-glaucoma targets. The specific nature of an
inherited LMX1B variant is suggested to contribute to differences in glaucoma subtype and
disease severity between individuals. We hypothesize that various LMX1B mutations have
differential mechanistic effects - affecting LMX1B function or the function of other proteins that
interact with LMX1B to regulate transcriptional activity/specificity. Our preliminary data support
this hypothesis. We will test our hypothesis in the following aims: Aim 1) Determine the impact
of selected Lmx1b mutations on phenotype and protein stability/function. Aim 2): Determine the
molecular mechanism by which Lmx1b mutations impact IOP. Aim 3) Determine if Lmx1b
impacts cellular metabolism and test a resilience boosting treatment.

Public health relevance
Project narrative High intraocular pressure is a key risk factor for glaucoma. This application will define and critically test key molecular events that control intraocular pressure in a mutant human glaucoma gene. Understanding these molecular processes will ultimately lead to a rational design of new treatment strategies to prevent glaucoma.